Center for Coordination of Analysis, Science, Enhancement, and Logistics (CASEL) in Tobacco Regulatory Science - Career Enhancement Core

PROJECT ABSTRACT – CAREER ENHANCEMENT CORE
The Career Enhancement Core (CEC) will provide professional development and educational resources
specific to tobacco regulatory science (TRS), enhancing the capacity of the research community to conduct
impactful TRS research. We will use a variety of established and innovative approaches, both virtual and in-
person, to expose students, trainees, postdocs, new and early-stage investigators, mentors, and seasoned
investigators to research experiences that increase their knowledge base and sharpen their TRS research
skills. Through our work on the Center for Evaluation and Coordination of Training and Research in Tobacco
Regulatory Science (CECTR) and the Center for Coordination of Analytics, Science, Enhancement and
Logistics (CASEL) 1.0, the Westat team is uniquely well-positioned to provide the infrastructure, networking,
and professional development opportunities needed to build the capacity and strength of the TRS research
community. The CEC will be led by Dr. Andrea Stroup, who currently leads the CEC in CASEL 1.0. As a former
TRS trainee in a Tobacco Center for Regulatory Science (TCORS), Dr. Stroup brings a valuable perspective to
her leadership role. Dr. Stroup will work collaboratively with the TCORS and other U.S. Food and Drug
Administration (FDA) Center for Tobacco Products (CTP)-funded grantees to develop educational resources,
collect and disseminate training resources, and provide networking and career development opportunities. We
will leverage and build on our experience, existing infrastructure and resources, and the expertise of our team
to achieve the aims of this Core.